Developmental Research Program

PROJECT SUMMARY-ABSTRACT (DEVELOPMENTAL RESEARCH PROGRAM)
Support for developmental research projects are a key SPORE element and are vital for
fostering pioneering initiatives. As such, we will support 3 developmental research projects with
budgets of approximately $50,000 each per year. The principal goal of the Developmental
Research Program (DRP) is to support highly innovative radiation therapy related cancer
research with high potential for translational impact, allowing investigators the ability to
obtain key preliminary data for submission of an R01 application or an equivalent
proposal (e.g. project in future SPORE application). A maximum of two years of support will be
possible; however, the expectation is that funds will support most projects for one year, with
10-15 new projects supported during the five-year period of the grant. Projects will be solicited
from University of Michigan Rogel Cancer Center investigators and other University of Michigan
faculty by campus-wide announcements and a standing advertisement for the Program at the
Cancer Center and institutional websites listing other developmental research opportunities.
Applications will utilize an NIH format, with a 5-page limit on the body of the application (e.g.
excluding references, detailed protocol information, appendix materials). Drs. Eric Fearon and
Theodore Lawrence will serve as Co-Directors of the DRP. The Cancer Research
Committee of the University of Michigan Rogel Cancer Center will undertake initial review,
evaluating each proposal’s scientific merit, innovation, relevance to the theme of
radiosensitization of locally advanced cancers and potential for translational impact. Given
the Cancer Research Committee’s rapid and successful annual review of more than 100 pilot
research proposals yearly in laboratory, clinical, and population-based research, the
Committee is well-suited for the initial review process. After initial review, the SPORE’s
Operations Committee will utilize assigned merit scores as a principal, but not sole, criterion in the
selection of proposals for support. Developmental research project investigators will take part in
all SPORE activities. Drs. Fearon or Lawrence will join mentoring committees set up for each
project PI to offer in-depth review and mentorship.